Distributed Neural Activity Patterns Underlying Practice-Based Learning

PROJECT SUMMARY
To survive, animals must learn appropriate associations between sensory cues and motor actions through
a process of trial and error. We expect that this learning will strengthen synaptic connections between
neurons representing the sensory cue and neurons initiating the motor action. The strengthened synapses
may be direct connections between these neuronal populations or via systems intermediate between them,
i.e., a “plastic brain circuit” or “pathway.” Synaptic plasticity has been observed in many brain areas, and
the mechanisms are moderately well understood. However, we have struggled to identify which plastic
brain circuit underlies, specifically, the sensory cue-to-motor action association learned through trial and
error. This is due, in part, to the fact that many brain areas undergo plastic changes during learning, as the
experience recruits a variety of cognitive processes, including sensory detection, motor control,
reinforcement learning, and memory recall—processes that all engage different brain areas and distributed
networks. I have developed an approach to assign these cognitive functions to distinct brain circuits for a
case of trial and error learning in mice. Specifically, sensory detection requires the visual cortex; motor
control requires brainstem circuits to control the forelimb; reinforcement learning requires the posterior
dorsomedial striatum tail (pDMSt); and memory recall requires the superior colliculus. We have discovered
a clear division of labor—the learning (pDMSt) and memory recall (superior colliculus) brain centers are
spatially separated. We will now identify the specific cells within the superior colliculus that store the
learned association to mediate memory recall. Hence, we aim to identify the precise site of an associative
memory in the brain. Finally, we will study interactions between the learning center (pDMSt) and the
memory recall center (superior colliculus) to understand the “neural handshake” between learning and
memory systems. To do this, we will optogenetically inactivate pDMSt while recording neural activity in
superior colliculus. This will reveal the component of the neural activity pattern in superior colliculus that
depends on input from pDMSt, which drives learning. This will allow us to characterize the “learning signal”
as it is transferred to the memory storage site, analogous to how information in computer RAM is written to
the hard drive. Finding the neural basis and mechanisms of such learned, sensory cue-motor action
associations will be essential to treat harmful associations, such as in PTSD, OCD, autism and anxiety,
without generally disrupting sensory or motor behavior.

Public health relevance
RELEVANCE: People and animals learn associations between sensory cues and motor actions. Typically, these associations are adaptive and support survival in a changing environment. However, some associations are harmful, for instance, in debilitating conditions such as addiction, PTSD, OCD, autism, and anxiety. Understanding how these associations are encoded in the brain is essential to developing targeted treatments. I will dissect neural pathways that acquire and store these learned associations.